ImplementatioN ScIence for Genomic Health Translation (INSIGHT)

PROJECT SUMMARY Despite enormous progresses in gene discovery and elevation of the concept of precision medicine into the scientific vernacular, such as the national AllofUS initiative, translation of this rich body of scientific knowledge into standard patient care has been slow, with broad implementation of genomics information into standard clinical practice facing a significant gap in management velocity. The goal of this project, ImplementatioN ScIence for Genomic Health Translation (INSIGHT), is to establish a generalizable paradigm guided by the principles of implementation science for scalable genetic testing, data integration, results interpretation and clinical decision support to guide routine health care for common complex disease traits, such as epilepsy. Epilepsy is a complex neuro-exemplar disease presenting in various clinical settings, in which genetic discovery has progressed to a point where DNA diagnostics is tractable, evidence- based, and advantageous for clinical care. Given the track-record of success of our multidisciplinary group in both integration of genomic information into clinical settings (such as the “HeartCare” project) and development of health data management platforms (such as an epilepsy-specific bespoke Electronic Medical Records [EMR] - EpiToMe), we will build on evidence and infrastructure established previously, to successfully integrate clinical genomics into clinical care, as well as create EMR tools that aid clinical, genomics based decision-making. First, we will identify and integrate disease susceptibility variants, drug-gene pharmacogenomics pairs, and deep phenotypic information into an intervention-ready genomic knowledgebase (iRGK) for patient care using epilepsy as a generalizable paradigm. In doing so, we will establish a pathway to place this body of translational knowledge in the context of precision intervention in patient care. Second, we will incorporate iRGK into an existing EpiToMe, resulting in creation of a health informatics platform (EpiToMe+); we will further link an existing clinical genomics reporting system (Neptune) and EpiToMe+. Clinical decision support interfaces will be created in EpiToMe+ to enable the practice of precision medicine. The coupling of the two systems will serve as an exemplar INSIGHT paradigm applicable to other disease areas. To pilot test the INSIGHT approach and the EpiToMe+ interfaces, we will enroll 120 patients drawn from the Texas Comprehensive Epilepsy Program, which is ethnically and economically diverse. We believe that this domain-specific, practical but generalizable INSIGHT approach will help catalyze a pathway to accelerate translation of genomic knowledge into impactful interventions in patient care. Conditions that fall under the same umbrella as epilepsy include but are not limited to cardiomyopathies, certain kidney and digestive disorders, and a list of familial or early onset cancers. Accomplishing this R21 study will also allow us to generate preliminary results for a future R01 application for the “Advancing Genomic Medicine Research” program.

Public health relevance
NARRATIVE The goal of this project, ImplementatioN ScIence for Genomic Health Translation (INSIGHT), is to establish a generalizable paradigm for integration of evidence-based clinical genomics practices into routine healthcare, which will lead to improved population health. This project will reveal opportunities to speed-up the delivery of genetic results and subsequent clinical intervention, and will make it easier for the physicians to choose the personalized care for their patients; moreover, due to the connection which will be established between the patient’s information and the genetic information, it will also drive new discovery. We will implement this approach in patients from the Texas Comprehensive Epilepsy Program, since epilepsy is a complex disease, presenting in various clinical settings, which is representative of many other diseases for which genetic testing is known to be tractable and advantageous, making the expected results of INSIGHT so generally applicable.